How E. coli Acid Response Mechanisms Breach Colonization Resistance in the Vagina

SUMMARY
This proposal will test the over-arching hypothesis that extra-intestinal pathogenic Escherichia coli
(ExPEC) overcomes inhibition by urogenital Lactobacilli via sequential activation of inter-connected acid
resistance (AR) mechanisms. We further postulate that transient internalization of ExPEC into vaginal epithelial
cells increases fitness by enhancing induction of acid resistance and other mechanisms of persistence that
enable bacteria to gain access and survive in otherwise harsh host environments. The hypothesis to be tested
has been formulated based on the following strong preliminary data: (1) We discovered a novel AR mechanism
in ExPEC that is controlled via a non-canonical signaling system, BtsS-YpdB and it uses L-serine deamination
to neutralize bacterial cytosolic pH. We call this new AR mechanism, AR6. (2) BtsS-YpdB signaling is induced
during infection and in response to several Lactobacillus species. (3) Deletion of btsS-ypdB significantly
decreases ExPEC acid tolerance and vaginal colonization. (4) Strains lacking L-serine deaminases, or BtsS-
YpdB differentially react to the inhibitory actions of representative urogenital L. gasseri and L. delbrueckii
isolates. (5) Deletion of btsS-ypdB alters the induction and function of the known acid-sensing system EvgSA
that controls the most prominent, known AR mechanism, AR2. We will test these hypotheses using the most
prevalent ExPEC pathotype, uropathogenic E. coli. Uropathogenic E. coli is the main cause of urinary tract
infections (UTIs), an infection that disproportionately afflicts women. Similarly, ExPEC strains are the leading
cause of infection-related stillbirths. Despite the dominant paradigm that the low pH of vagina is protective against
pathogens, we and others have shown that colonization of the vagina by ExPEC can serve as a nidus for infection
of the urinary tract, the cervix, uterine horns and the gravid uterus. Vaginal colonization is therefore a key step
in pathogenesis. While several acid resistance (AR) mechanisms have been identified that are active in the gut,
the relative contribution of each AR mechanism during ExPEC infection remains undefined. With our aims, we
will: Interrogate the significance of transient bacterial expansion in the host as a priming niche for the
amplification of acid resistance and other persistence mechanisms (Aim 1). We will evaluate the individual and
combined contributions of AR mechanisms to the colonization potential of ExPEC in the vagina, bladder and gut
and will elucidate the connection of the novel AR6 pathway we discovered to the induction and function of AR2
(Aim 2). Finally, building on exciting preliminary data we will investigate the potential of urogenital Lactobacilli
strains in their ability to override ExPEC acid resistance, aiming to identify effective probiotic strategies to prevent
ExPEC reservoir formation in the vagina (Aim 3). Completion these aims will uncover how ExPEC leverage
their multiple AR systems to transit the host and evade elimination and will inform our efforts towards
developing effective probiotic strategies to prevent, vaginal colonization and combat genitourinary tract
infections.

Public health relevance
PROJECT NARRATIVE Despite the acidic environment of the vagina – created by members of the vaginal microbiota – bacterial pathogens such as uropathogenic Escherichia coli (UPEC) can overcome acidification and colonize the vaginal space. Colonization of the vagina by UPEC can lead to urinary tract infection, or infection of the cervix and uterine horns, which can have adverse sequelae during pregnancy. This proposal will elucidate how UPEC uses its several acid resistance systems to establish a niche in the vagina and will explore the potential of overriding these acid resistance mechanisms as a prophylaxis against genitourinary tract infection.